Evaluating the Efficacy of Sequenced Central Executive and Behavioral Parent Training for Children with ADHD

PROJECT SUMMARY/ABSTRACT
The goal of the current project is to combine two evidence-based treatments for school-aged children with ADHD:
Central Executive Training (CET) and Behavioral Parent Training (BPT). CET is a computerized training
intervention that improves ADHD symptoms and academic functioning by improving children’s working memory
abilities. BPT is a therapeutic intervention that improves family functioning and child ODD symptoms by changing
parenting behaviors. Their combined use is expected to provide complementary and additive benefits, particularly if
CET is delivered before BPT.

Public health relevance
PROJECT NARRATIVE The goal of the current project is to combine two evidence-based treatments for school-aged children with ADHD: Central Executive Training (CET) and Behavioral Parent Training (BPT). CET is a computerized training intervention that improves ADHD symptoms and academic functioning by improving children’s working memory abilities. BPT is a therapeutic intervention that improves family functioning and child ODD symptoms by changing parenting behaviors. Their combined use is expected to provide complementary and additive benefits, particularly if CET is delivered before BPT.